Optimizing autophagy to counteract aging-induced muscle deterioration in mice

Some pharmacological agents alleviate aging-induced loss of muscle mass and function (i.e.,
sarcopenia) when prescribed as a single-mode therapy, but combining them with exercise has
produced frustrating outcomes. Thus, identifying a pharmacological agent that enhances exercise
benefits is an unmet need in this field. Our long-term goal is to uncover crucial mechanisms of
sarcopenia to identify effective therapeutic strategies to prevent, stop, or reverse the progression
of this muscle degenerative condition. It is postulated that because there is an accumulation of
autophagic substrates, including protein aggregates and dysfunctional mitochondria in aging
muscles, autophagic activity is decreased. The mechanism by which autophagy is suppressed in
aging muscles remains poorly understood. The Golgi-associated plant pathogenesis-related
protein 1 (GAPR-1) is a potent negative regulator of autophagy. GAPR-1 suppresses autophagy
by physically interacting with Beclin1, a protein inducing autophagy. Since fine autophagy
regulation is required for maintaining muscle mass and function, the central hypothesis is that
combining Tat-Beclin1, a specific autophagy agonist disrupting Beclin1/GAPR-1 interaction, may
enhance endurance exercise benefits in aging muscles. The hypothesis will be tested with two
specific aims. 1) Define the role of GAPR-1 in sarcopenia; and 2) Determine the efficacy of
combining Tat-Beclin1 with endurance exercise in halting sarcopenia progression in aging mice.
In aim 1, in vivo muscle gene transfer by electroporation to overexpress or knockdown GAPR-1
into tibialis anterior will be applied to determine whether GAPR-1 regulates sarcopenia in 24-
month-old mice of both sexes. In vivo muscle contractility assays, comprehensive biochemical
and morphology phenotype will be examined. Under aim 2, a combination of Tat-Beclin1 with
endurance exercise will be applied in 22-month-old mice of both sexes for four months.
Functional, biochemical, morphological, and molecular (i.e., proteomics) will be assessed. This
proposal is innovative because it centers on uncovering a new molecular mechanism contributing
to sarcopenia and testing Tat-Beclin1 as a pharmacological agent enhancing exercise benefits in
aging muscles by optimizing autophagy. The proposal is significant because it addresses a
relevant and poorly understood area of muscle biology, and it could put into development a new
therapeutic approach to tackle sarcopenia.

Public health relevance
Project Narrative Aging causes a gradual loss of muscle mass and function (i.e., Sarcopenia). Unfortunately, there is no approved treatment for this muscle degenerative condition, which may be due to the lack of effective therapeutic approaches capable of counteracting its multifaceted nature. Thus, this proposal focuses on developing a new combined approach to optimizing the clearance of markedly accumulated wasting material in aged muscles.